UT Southwestern Center for Translational Medicine

The UT Southwestern Center for Translational Medicine’s KL2 Scholars Program has a record of supporting Scholars who have become leaders in clinical and translational research (CTR). Our KL2 program, with an ethos of continuous improvement based on metrics and changing needs, has been a model of unique and centralized CTR training in our Hub. Our training curriculum has been streamlined and modernized, and the exposure of our Scholars across all important domains has steadily increased. KL2 Scholars engage in mentored research training, take formal coursework and nano courses on emerging CTR topics. Scholars submit manuscripts and grant proposals to secure individual career development and/or research grants (K2K and K2R conversion) in a timely manner. Program evaluation guides us to restructure elements as needed to increase the range of those we train and broaden the disciplines and institutions from which the Scholars are recruited. The KL2 program plan proposed here is significant and innovative. We will strategically leverage our CTSA Program hub and institutional resources to broaden the KL2 program’s impact and provide CTR training to our expanding biomedical workforce.